An Ecological Momentary Assessment Study of Appearance-Related Safety Behaviors

Project Summary. Appearance concerns are a common component of several psychiatric disorders including
body dysmorphic disorder (BDD), eating disorders (EDs), and social anxiety disorder (SAD)1-3. Given the
transdiagnostic nature of these concerns, it is crucial to identify key targets that can improve these concerns.
Appearance related safety behaviors (ARSBs), or maladaptive behaviors aimed at checking, concealing, or
fixing perceived flaws in appearance have been shown to be strongly related to appearance concerns,
symptoms of BDD, ED, and SAD, as well as depression4,7. Additionally, experimental research has
demonstrated that instructions to reduce these behaviors led to lower appearance concerns and symptoms of
BDD, ED, and SAD, demonstrating their transdiagnostic importance14. Consistent with the NIMH Research
Domain Criteria (RDoC) initiative, ARSBs represent a transdiagnostic construct relevant to multiple psychiatric
disorders that can potentially be targeted to yield improvements across an array of highly comorbid disorders.
While there is a growing body of research on ARSBs, little is known about how these behaviors vary within a
day and their potential causes and consequences. This is a crucial gap in the literature that the present study
aims to fill. The present proposal will be a novel examination of these behaviors using ecological momentary
assessment (EMA). Specifically, this study will (a) use EMA to examine what situational or contextual triggers
precede ARSB use, (b) examine how within day ARSB use will precede and predict increases in appearance
concerns as well as symptoms of BDD, EDs, and SAD, (3) determine how these relationships vary between
individuals who are high in appearance concerns compared to those low in these concerns, and (4) examine
how symptoms of BDD, EDs, and SAD moderate these relationships. Results of the present study would
advance the knowledge on the processes surrounding ARSB use and provide a better understanding of how
these behaviors contribute to the risk for body dysmorphia, eating pathology, and social anxiety. This proposal
has important implications for the prevention and treatment of these appearance-related disorders. Through
this proposed study, the applicant will acquire additional training and experience in the design and execution of
intensive longitudinal study design, advanced statistical techniques, and professional development crucial for
an independent clinical researcher. The experience that can be gained from this fellowship will lay the
foundation for the applicant to become an independent clinical scientist who investigates transdiagnostic
pathology. Coupled with extensive education in computerized treatments gained from the applicant’s lab, the
experience from this fellowship will enhance the applicants ability to identify and target malleable mechanisms
of psychopathology. This fellowship will provide crucial experience to bolster the applicant’s goal of identifying
targets for the development of more efficacious treatment for psychopathology.

Public health relevance
PROJECT NARRATIVE Appearance concerns represent a key factor present in multiple psychiatric disorders that contribute to a major public health burden. Appearance related safety behaviors (ARSBs) represent a risk factor for the development and maintenance of body dysmorphic disorder, eating disorders, and social anxiety disorder; however, research has yet to identify how these behaviors fluctuate within a day, how these changes affect subsequent symptoms, and what precedes the use of these behaviors. This study has the potential to provide a better understanding of how these behaviors may be a response to certain situational triggers and how they affect different symptoms in daily life.